THE EFFECT OF DIET ON POSTPRANDIAL LIPEMIA AND PLATELETS IN DIABETIC SUBJECTS

Diabetic patients may have prolonged postprandial lipemia and abnormal platelets after ingestion of fat and cholesterol. This might be a crucial element in the greater propensity to atherosclerosis that diabetic patients have. Postprandial response will be assessed through a 24-hour period. If patients have prolonged postprandial lipemia, this study would provide further documentation for use of low-fat, low-cholesterol diet and for use of omega-3 fatty acids to prevent postprandial lipemia in these patients.